Modulation of mitochondrial respiration to treat colitis

The importance of mucosal healing in inflammatory bowel disease (IBD) derives from clinical data that
demonstrate it to be a predictor of remission. Unfortunately, many IBD patients remain refractory or lose
responsiveness to therapies leading to persistent mucosal ulceration. Prospective pediatric studies show that
reduced mitochondrial gene expression predict unfavorable outcomes in ulcerative colitis (UC). Consistently,
increased expression of mitochondrial respiratory chain genes has been shown to predict favorable Crohn’s
disease (CD) outcomes. Based on these results and our own data, we hypothesize that a critical driver of chronic
ulceration in IBD is the failure of intestinal epithelial cells (IEC) to increase mitochondrial respiration. In studies
leading up to this submission we found that mitochondrial deficiency caused poor ulcer healing due to inadequate
crypt fissioning occurring at ulcer edges (Progress Report). These findings led us to develop a novel gold (Au)-
based drug based on the current safe and effective gold therapy for Rheumatoid arthritis (Auranofin). This new
drug, AuPhos, localizes to mitochondria where it increases mitochondrial respiration and mitochondrial reactive
oxygen species (mtROS) production. Induction of low levels of “endogenous” mtROS are known to promote
healthy adaptive responses in cells including anti-oxidant enzyme activities (Background). In preliminary
studies, we found that oral AuPhos 1) enhances mucosal repair in DSS colitis, 2) increases IEC mitochondrial
oxygen consumption rate (OCR) and oxidative phosphorylation (OXPHOS), 3) mtROS and H2O2 production in
IEC as well as 4) phosphoinositides-3 kinase (PI3K) and nuclear factor erythroid 2-related factor (Nrf2) signaling
with 5) improved expression of proteins that induce mitochondrial biogenesis [peroxisome proliferator activated
receptor-γ coactivator 1 alpha (PGC1α) and transcription factor A, mitochondrial (TFAM). Studies proposed in
Aim 1 interrogate mitochondrial function under baseline conditions to allow assessment of AuPhos-induced
changes in mitochondrial mass, activity (mtROS) and OCR, ATP turnover, electron transport chain (ETC) activity,
induction of adaptive responses [anti-oxidant catalase, MnSOD (superoxide dismutase) and glutathione
(reduced/oxidized)] as well as assess changes in tissue oxidant stress (4HNE, protein carbonylation,
nitrotyrosine IHC). Aim 2 will build upon these studies by evaluating AuPhos effects in TNF-stimulated small
bowel (SB) and colonic organoids from veterans (normal and IBD). Studies in 3D organoids will allow for
mechanistic testing of AuPhos-induced crypt budding and IEC gene expression. Results of Aim 2 will instruct
studies in Aim 3A that study therapeutic effects of AuPhos on IEC gene expression and crypt fissioning that
heal ulcers in DSS colitis. In Aim 3B, scRNAseq analysis of human biopsies incubated with AuPhos will allow
us to examine induction of mitochondrial gene expression in discrete IEC clusters. Proposed studies are driven
by a novel hypothesis that restoration of IEC mitochondrial respiration is a key step in mucosal healing. Together,
these “preclinical” studies with a VA-sponsored new drug (AuPhos) have the potential of transitioning this agent
to the therapy of IBD in veterans.

Public health relevance
The increase in inflammatory bowel disease (IBD) among veterans in recent years presents a significant clinical problem in the VA healthcare system. Major concerns for IBD veteran patients are the increased disease morbidity and risk of therapies. Further research is needed to develop safe and effective agents that enhance mucosal repair and reduce immune-suppression. Previous work from our lab has indicates that mitochondrial respiration promotes ulcer healing. This finding led us to postulate that increasing mitochondrial respiration constitutes a novel therapeutic goal in IBD. To improve mitochondrial function in IBD, we developed AuPhos, an oral agent that enhances mitochondrial electron transport that potentiates mitochondrial bio-energetics and mitochondrial reactive oxygen species (mtROS) production. The current project will ascertain the impact of this novel gold compound (AuPhos) on mitochondrial function and ulcer healing in mouse models of colitis as well as biopsy tissue explants from veterans with IBD.